Elucidating the interplay between cohesin-mediated loop extrusion and heterochromatin in single cells.

Project Summary
Fragile X Syndrome (FXS) is characterized by the unstable expansion of a CGG short tandem repeat (STR)
located in the 5’ untranslated region of the Fragile X Messenger Ribonucleoprotein 1 (FMR1) gene. Expansion
of the CGG tract from normal-length (WT, <55 CGG) to mutation-length (ML, >200 CGG) results in silencing of
FMR1 transcription and severe loss of the protein it encodes. Textbook models of FXS have long attributed
FMR1 silencing to local DNA methylation over the promoter and CGG tract, however removal of methylation is
insufficient to reproducibly de-repress the gene in many experiments. Recently, my lab discovered a Megabase-
scale domain of H3K9me3 on the X-chromosome and multiple autosomes in FXS induced pluripotent stem cell
(iPSC) lines with a mutation-length CGG tract. The H3K9me3 domains encompass repressed synaptic genes,
including FMR1, and severe misfolding of the 3D genome. The overall objective of my proposal is to investigate
the interplay between cohesin-mediated loop extrusion, H3K9me3, and gene expression in FXS at the resolution
of single-cells. Progress toward testing this goal has been limited by the paucity of single-cell approaches for
mapping cohesin occupancy and chromatin folding at kilobase-resolution. My central hypothesis is that the
FMR1 locus can undergo cohesin-mediated loop extrusion in WT-iPSCs. By contrast, I posit that ML-FXS iPSCs
with H3K9me3 domains will exhibit depleted cohesin binding that is functionally linked to severely misfolded
topologically associating domains (TADs), subTADs, and loops and silenced FMR1 expression. I generated my
hypotheses based on (1) published work demonstrating that depletion of the cohesin unloading factor WAPL
causes hyper-extrusion, stabilization of cohesin binding, and loss of H3K9me3 signal, and (2) my own preliminary
data showing that loops are abolished at H3K9me3 domains in ML-FXS iPSCs and rescued when H3K9me3
signal is reversed. I will test my hypothesis by employing both single-cell imaging and genomics techniques to
map genome folding, immunofluorescence staining of cohesin and H3K9me3, and single-cell TIPseq to assay
cohesin binding and H3K9me3 in WT and ML-FXS iPSCs. I will also utilize WAPL degron iPSC lines established
in my lab in ML genetic backgrounds to assay changes in genome folding due to loss and gain of cohesin
extrusion at the FMR1 locus. Upon successful completion of my experiments, I will have elucidated mechanisms
underlying the interplay between chromatin folding and H3K9me3 maintenance in FXS. My work is significant
because knowledge generated in this proposal will have impact on our understanding of how heterochromatin
disrupts gene expression in a wide range of neurodevelopmental and neurodegenerative disorders. In addition,
I will create freely available algorithms to quantify cohesin-mediated loop extrusion from chromatin tracing data.

Public health relevance
Project Narrative Fragile X syndrome (FXS) is the most common cause of heritable intellectual disability, thought to be driven by instability of a CGG short tandem repeat tract and local DNA methylation of the FMR1 gene. We have recently observed a large Megabase-sized domain of heterochromatin encompassing silenced long synaptic genes and co-localized with severe misfolding of the 3D genome. Using cutting-edge imaging techniques coupled with genomics methods and new computational analyses, I will investigate the interplay between cohesin-mediated loop extrusion and heterochromatin in single-cells in the context of FXS.